Investigating Cardiac Ion Channels by Novel Methods

In patients with heart failure (HF), the continual activation of the sympathetic nervous system, which
compensates for lower cardiac output, harms the heart. This not only worsens HF but also increases the risk of
life-threatening arrhythmias. Although β-adrenergic receptor agonists and phosphodiesterase inhibitors were
commonplace, seminal studies revealed reduced survival. β-adrenergic receptor agonists and PDE inhibitors
are still utilized, although their use is limited by the need for intravenous administration and close monitoring
due to potential arrhythmias. A notable gap exists in our understanding and treatment approaches for the
short- and long-term management of HF, particularly regarding the safe, direct targeting of myocyte
contractility by enhancing calcium influx and transient levels. Our long-term aim is to deploy innovative
strategies to identify and evaluate targets for targeted therapies for arrhythmias and HF. Over the last five
years, we have uncovered the mechanisms behind the adrenergic regulation of cardiac calcium channels. We
discovered that the RGK G-protein Rad, which inhibits high-voltage activated calcium channels, is a crucial
PKA target within the CaV1.2 complex. PKA phosphorylation at two Ser residues on Rad's C-terminus causes
Rad to detach from the membrane, decreasing its affinity for CaVβ and relieving CaV1.2 inhibition. Unlike the
pro-arrhythmic effects seen with the inotropic drug BayK 8644—which increases calcium influx by slowing the
inactivation properties of CaV1.2—up-regulating calcium influx through the expression of a CaVβ2B subunit that
does not interact with Rad does not appear to have any detrimental effects or induce arrhythmias. These
results challenge the prevailing belief that all increased calcium influx is harmful or that all animal models
featuring elevated calcium influx will inevitably suffer from HF or arrhythmias. Enhancing calcium influx, like
adrenergic stimulation, may be more precise and effective than traditional methods, as it avoids harmful SR
calcium leak and overload associated with adrenergic agonists. To this end, we have created gene and base
editors capable of introducing either a frame-shift insertion/deletion (indel) in Rad or a mutation in the calcium
channel β-subunit to prevent Rad binding in cardiomyocytes. This editing is achieved through AAV9 injections
subcutaneously in young pups or retro-orbitally in adult mice. Additionally, we have devised a base-editing
strategy to significantly reduce adrenergic regulation of calcium channels while sparing the basal function of
CaV1.2 channels, which may help prevent arrhythmias induced by adrenergic agonists. We propose three
specific aims: Aim 1: To determine whether enhancing calcium influx through Rad or CaVβ2 gene editing can
slow the decline of cardiac function in non-ischemic HF models. Aim 2: To determine if increased calcium influx
can restore cardiac function after HF onset. Aim 3: Investigate whether restricting the sympathetic nervous
system’s enhancement of Ca2+ influx can attenuate the cardiac dysfunctions associated with catecholaminergic
polymorphic VT (CPVT) and hypertrophic cardiomyopathy (HCM).

Public health relevance
Cardiac Ca2+ channels have a key role in excitation-contraction coupling and hormonal modulation of cardiac function. Dysregulation of basal activity and of hormonal modulation of Ca2+ channels is associated with major cardiovascular diseases, such as heart failure, hypertrophy and arrhythmias. Our goals are to develop a novel and potentially transformative approach for enhancing cardiac function in vivo.